A Type 1 Hybrid Effectiveness-Implementation Evaluation of a City-Level Transitional Housing Program's Effects on Health, Economic, and Psychologic Outcomes Among People with HIV

ABSTRACT
The US is currently on pace to fall short of achieving the goals set by the Ending the HIV Epidemic (EHE) initiative
launched by the Department of Health and Human Services in 2019. A growing body of research suggests that
the root causes of EHE's striking lack of progress are structural racism and social stratification that leads to
poverty. Housing instability — a lack of stable, secure, and adequate housing that results from poverty and
structural racism — is a major social determinant of health (SDOH). The Philadelphia Department of Health
(PDPH) estimates that 4,000 people with HIV (PWH) experience housing instability in Philadelphia. While the
National HIV/AIDS strategy specifically calls for approaches to address SDOH (including through the
development and scaling up of housing interventions), the vast majority of EHE efforts continue to focus on
facilitating healthcare access and uptake. There have been few rigorous evaluations of housing interventions for
PWH, and even fewer during the modern era of universal treatment for HIV. In close partnership with the PDPH,
we will rigorously evaluate a potentially transformative city-level transitional housing program for PWH
experiencing housing instability (“Arms Around You” or AAY), leveraging lottery drawings from a waitlist to
estimate causal effects. The program will be implemented by PDPH in 2024 and scaled up in the coming years
(~200 anticipated enrollments during the first several years). AAY includes (1) intensive housing counseling, (2)
housing medical case management, and (3) full rent payment support for 48 months (or longer if needed). We
will use mixed methods to collect quantitative (survey data, pharmacy refill data, and PDPH surveillance/program
data) and qualitative (key stakeholder interviews) data. If the AAY screening period begins before this proposal's
full review by NIH, we have pilot funding from PDPH to collect baseline data. Since PDPH's lottery drawing is
necessitated by high anticipated demand (PDPH estimates there are 4,000 PWH in Philadelphia experiencing
housing instability) and limited initial availability (~200 available spots during the first few years), we will be able
to estimate the long-term effects of the program on health, economic, and psychological outcomes. In addition
to studying mechanisms through which housing interventions affect health outcomes, we will use implementation
science methods to assess program acceptability, reach, sustainment, and costs to inform scalability to other
cities. This proposal is innovative in that we will capitalize on a unique opportunity to use rigorous causal and
implementation science methodology to evaluate the health and non-health effects of a population-level large-
scale housing intervention that addresses an important SDOH. This approach could significantly impact both
HIV- and non-HIV-related outcomes, such as viral suppression, ART adherence, engagement in care, substance
use, financial well-being, housing security, food security, psychological distress, hope, and future orientation.
This study will provide critical evidence to policymakers at a time when many cities are considering housing
support programs and various other anti-poverty interventions (e.g., guaranteed income).

Public health relevance
PROJECT NARRATIVE Housing instability — a lack of stable, secure, and adequate housing that results from poverty and structural racism — is a major social determinant of health for HIV and one of the reasons for the striking lack of progress toward goals to end the HIV epidemic in the US. In this study, we will rigorously evaluate a potentially transformative city-level transitional housing program for people with HIV experiencing housing instability, leveraging lottery drawings from a waitlist to estimate causal effects and conducting an implementation evaluation. This approach could significantly impact both HIV- and non-HIV-related outcomes, and this study will provide critical evidence to policymakers at a time when many cities are considering housing support programs and various other anti-poverty interventions (e.g., guaranteed income).